Mediators and Modifiers of Prenatal Environmental Exposures and Child Neurodevelopment: DNA methylation, Prenatal Diet, and Cognitive Stimulation (MEND)

PROJECT SUMMARY/ABSTRACT
Prenatal exposure to neurotoxic chemicals can have long-lasting effects on child neurobehavioral outcomes.
The majority of published studies focus on isolated exposure-outcome associations, ignoring the potential for
synergistic effects of multiple exposures on a broad range of neurobehavioral outcomes and failing to identify
mechanisms of action and targets for intervention. The proposed study, Mediators and Modifiers of Prenatal
Environmental Exposures and Child Neurodevelopment: DNA methylation, Prenatal Diet, and Cognitive
Stimulation study (MEND), addresses these gaps, leveraging extant and prospective data collected in the NIH
Environmental Influences on Child Outcomes project to study the effects of phthalates and organophosphate
flame retardants (OPFRs) on child neurobehavior. These compounds are of particular importance both
because they are ubiquitous in the environment and because they are believed to exert neurotoxicity through
shared mechanisms (e.g., oxidative stress, DNA methylation). Our study will continue the PATHWAYS-GAPPS
(PWG) cohort, a diverse sample of over 650 participants recruited from rural and urban communities in
Washington state with rich prenatal and longitudinal data. Our long-term goals are to identify mechanisms of
neurotoxic exposure and actionable targets for intervention that could attenuate the effects of those exposures.
We propose the following: Aim 1. Examine the relationship between prenatal exposure to phthalates and
OPFRs, cord blood DNA methylation, and child neurobehavior and assess prenatal dietary oxidative balance
as a potential modifier. Aim 2 (a) Use machine learning to develop multi-outcome phenotypic profiles of child
neurobehavior; (b) Employ these profiles to examine the relationships between prenatal phthalates and
OPFRs, cord blood DNA methylation, prenatal dietary oxidative balance, and child neurobehavior; (c) Explore
whether parental cognitive stimulation modifies the relationship between prenatal phthalates and OPFRs and
child neurobehavioral outcomes, including established constructs and novel phenotypic profiles. Aim 3. (a)
Retain a diverse sample of participants using tailored strategies such as sharing ECHO-wide and individual
results and (b) implement the ECHO protocol with high fidelity. Our team has the complementary expertise to
carry out these ambitious aims. Consistent with the NIH/ECHO mission to enhance diverse perspectives, our
team includes four under-represented minorities and a mix of junior investigators and senior investigators with
a strong track record of research mentorship. The

Public health relevance
PROJECT NARRATIVE Exposure to environmental chemicals, such as phthalates and organophosphate flame retardants (OPFRs), during pregnancy can impact the developing fetal brain. Existing studies focus on the effects of isolated exposure to these compounds rather than the multiple exposures common in real-world settings, and we know very little about potential protective factors that can help like mothers’ prenatal nutrition and cognitively stimulating interactions between parents and young children. This study will be the first to examine several child neurobehavioral outcomes associated with combined exposure to phthalates and OPFRs, and the potential for maternal nutrition and parental cognitive stimulation to improve outcomes.